HEAL Initiative: Neonatal Opioid Withdrawal Syndrome Pharmacological Treatments Comparative Effectiveness Trial Clinical Site

PROJECT SUMMARY/ABSTRACT
The University of Arkansas for Medical Sciences (UAMS) will be a clinical site for the HEAL Initiative: Neonatal
Opioid Withdrawal Syndrome Pharmacological Treatments Comparative Effectiveness Trial-Clinical Sites (UG1),
RFA-HD-21-031. Arkansas (AR) is a rural state with the second highest opioid prescription rate in the nation and
is in the top 3 states nationwide for opioid prescriptions to pregnant mothers. Additionally, AR has the second
highest number of Adverse Childhood Experiences in the nation, thus making this an ideal site to study the effects
of opioid use in a state with other environmental stressors. Recruitment will be from a robust Women's Mental
Health Program, which saw 899 pregnant women with opioid use disorder last year, the general obstetrical clinic,
and the 64 bed academic Neonatal Intensive Care Unit (NICU) at UAMS. Innovative strategies for recruitment will
include investigator attendance at prenatal classes and a Community Advisory Board, while retention will be
bolstered by frequent electronic communication, updated contact information, financial and scheduling
incentives. Follow-up will be performed at the Arkansas Children's Hospital Research Institute in a state of the
art Pediatric Clinical Research Unit. Compliance for follow-up is anticipated to be challenging for this trial, so
innovative strategies to encourage compliance will include monetary incentives, ease of scheduling, and case
managers to arrange free travel, meals, and other needs for participants. Parents will also be given results of their
psychological exams to encourage compliance. This project is well supported by the Translational Research
Institute (TRI), home of a Clinical and Translational Science Award. This site has extensive experience conducting
multicenter trials and is currently involved in two similar trials, which will be completed by the time this site will begin
enrolling patients assuring this site will be ready to begin enrollment after funding. This site also has extensive
experience in opioid research and will actively contribute to protocol development. Major strengths of this site
include experience in pk/pd modeling, a robust telemedicine program to bolster awareness of the study statewide,
and a Center for Implementation Science to implement evidence based weaning medication. This site has a large
diverse clinical population with an average of 3450 annual deliveries, approximately 10% of the state's annual
deliveries, with 273 opiate exposed neonates and 49 pharmacologically treated newborns annually. There are
53% white, 33% African American and 11% Hispanic mothers who deliver annually at UAMS. Public insurance
accounts for 81% and private insurance accounts for 16% of all newborn admissions. This site has an excellent
track record of participation in multicenter trials (12 trials are open currently) and a robust scholarly publication
record. The assembled group of researchers at this site will contribute to the analysis, interpretation, and
publication of results. The environment at this site is supportive of this initiative, and leadership will provide the
support, protected time, and the infrastructure to successfully complete the study.

Public health relevance
PROJECT NARRATIVE This project will have adequate power and collaborative input to determine the best pharmacological therapy for NOWS, comparing morphine, methadone, and buprenorphine in a head to head trial for the first time. This site, by virtue of its large diverse, rural population, its previous research experience in NOWS, opioid use, pk/pd modeling, and implementation science, and support from the Translational Research Institute and CTSA, is well positioned to become an active member of this collaborative effort. This site will advance NIH's mission to effectively and safely treat NOWS and participate in all aspects of this important comparative effectiveness trial.